GM-CSF, macrophages, and susceptibility to Mycobacterium abscessus pulmonary infection

GM-CSF, macrophages, and susceptibility to Mycobacterium abscessus pulmonary infection
Nontuberculous mycobacteria (NTM) do not cause disease in healthy individuals; however, people with chronic
airways diseases are susceptible to developing pulmonary NTM infections (pNTM), which increase symptom
burden and accelerate lung function decline. How the healthy lung clears inhaled NTM and why individuals with
airways disease are at increased risk of developing pNTM remain poorly understood. Our long term goal is to
understand how macrophage heterogeneity contributes to chronic lung diseases. The objective of this grant is
to characterize events that occur when inhaled NTM initially interact with respiratory tract macrophages, and
determine how the cytokine granulocyte macrophage colony stimulating factor (GM-CSF) promotes clearance
of NTM. Data from human case reports and mice lacking GM-CSF (GM-CSFKO mice) indicate that GM-CSF is
essential for immune control of pNTM. We have chosen to study the role of GM-CSF in susceptibility to
Mycobacterium abscessus (MAbsc) as this species causes a significant portion of pNTM, is increasing in
prevalence, and is especially challenging to eradicate. Our data demonstrate that GM-CSF can activate
macrophages to kill MAbsc. In lung airspaces, macrophages can be grouped into two main categories: resident
alveolar macrophages (AlvMs) and recruited monocyte-derived macrophages (MDMs). AlvMs are constitutively
exposed to GM-CSF produced by alveolar epithelial cells. In contrast, most macrophages in airways of people
with chronic airways disease are MDMs recruited from the bloodstream, a compartment with low levels of GM-
CSF. Our central hypothesis is that macrophages must be activated by GM-CSF to eliminate NTM, and that
MDMs recruited to the airways in people with chronic airways disease are less effective at killing NTM than
AlvMs due to insufficient exposure to GM-CSF. We will investigate this hypothesis in three specific aims. Aim 1
will determine the mechanism by which GM-CSF enhances macrophage killing of MAbsc, testing the hypothesis
that GM-CSF promotes phagosomal maturation and phagolysosomal acidification. Using conditional knockout
mice that lack the GM-CSF receptor on different macrophage subsets, Aim 2 will test the hypothesis that resident
AlvMs programmed by GM-CSF are the essential cells responsible for control of MAbsc in the healthy lung. Aim
3 will employ a mouse model of airway infection using MAbsc-embedded agar beads to test the hypothesis that
there is insufficient GM-CSF in the airways to activate recruited MDMs to develop mycobacteriocidal phenotypes.
These studies are innovative, as they will determine the mechanisms by which GM-CSF enhances macrophage
killing of MAbsc, and reveal how location in the lung influences phenotypes of recruited MDMs. The results from
the proposed research will be significant, as they will inform use of immune therapies to treat non-resolving
infection in chronic lung diseases, and they could help predict which individuals with chronic lung diseases are
at highest risk for developing pNTM.

Public health relevance
PROJECT NARRATIVE This proposal aims to understand why nontuberculous mycobacteria (NTM) act as opportunistic pathogens that are readily cleared by healthy lungs but can cause pulmonary infections in individuals with chronic airway diseases. Using animal models and human cells, we will characterize initial events that occur when NTM interact with specific immune cells (macrophages), and demonstrate how local environments within different parts of the lung determine whether or not macrophages can kill inhaled NTM. Results from the proposed research will aid development of novel therapies to treat non-resolving NTM infections in people with chronic airway diseases.